Investigating the role of the Sigma-1 receptors in alcohol addiction and associated cognitive deficits and pain states

Abstract Alcohol use disorder (AUD) is a highly prevalent chronically relapsing disorder characterized by compulsion to seek and take alcohol and deficits in cognitive and executive function. These symptoms include disturbances in impulse-control, cognitive deficits, and inability to control alcohol intake. These behaviors are mediated through chronic alcohol-induced neuroadaptations in fronto-cortical regions of the brain, such as the anterior cingulate cortex (ACC) ? brain areas key for the “top-down” inhibitory control over behavior. The ACC is also a hub for neuropathic pain, therefore, a potential key site for alcohol-induced hyperalgesia. Several gaps exist in our current knowledge of how these fronto-cortico regions of the brain mediate these executive function deficits as well as alcohol-induced hyperalgesia. One potential mechanism is through the sigma-1 receptor (Sig-1R). We have found that exposure to chronic intermittent ethanol (CIE) increases Sig-1R levels in the ACC. Sig-1R antagonists decrease excessive alcohol drinking and motivation in rats exposed to chronic intermittent ethanol (CIE), and they have been shown to alleviate neuropathic pain. Whether Sig-1Rs in the ACC play a role in excessive alcohol drinking, loss of inhibitory control, and allodynic state remains unclear. Here we hypothesize that hyperactivation of Sig-1R in the ACC is caused by chronic alcohol exposure and plays a key role in alcohol addiction and in the associated cognitive dysfunctions and allodynia. Sig-1R is a molecular chaperone that plays a key role in glutamatergic signaling, specifically through modulation of the N-methyl-D- Aspartate (NMDA) receptor. The NMDA receptor, especially within the ACC, plays a key role in pain sensitivity, alcohol intake and executive function. Thus, I hypothesize that the increases of Sig-1R levels leads to NMDA receptor redistribution in the ACC, increasing synaptic levels of NMDA subunit GluN2b, hereby driving the addiction process forward. To test these hypotheses, we will use a viral vector to knockdown Sig-1R in the ACC prior to exposing them to CIE. Rats will then be tested for excessive alcohol drinking, impulsive action, and mechanical allodynia. Furthermore, we will investigate physical interactions between Sig-1R and GluN2b and the effect of Sig-1R knockdown on subcellular localization of GluN2b. The results of these experiments will give important insights into the role of Sig-1Rs of the ACC in alcohol addiction, and may lead to the development of novel pharmacological treatments for AUD.

Public health relevance
PROJECT NARRATIVE Alcohol use disorder is a chronic, relapsing disorder of compulsive alcohol use associated with dysregulation of executive function and increased pain sensitivity. The studies outlined in this proposal will provide original insights into the neurobiological bases of alcohol addiction and will provide novel potential targets for treating alcohol use disorder.